Neurophysiological reward responsiveness, stress, and depressive symptoms across the perinatal period

PROJECT SUMMARY/ABSTRACT
Perinatal depression (i.e., depression during pregnancy and following childbirth) is a prevalent and debilitating
condition that is associated with significant impairments in maternal functioning and negative impacts on
offspring, making the identification of targets for prevention critically needed. Neuroscience research outside of
the perinatal period has shown a prospective association between reduced neural reward responsiveness and
depression, but the extent to which depression further alters reward responsiveness has yet to be examined.
The perinatal period presents a unique time of adaptations of the reward system which have implications for
the development of depression, but neuroscience research has primarily been limited to the postpartum period
due to concerns about the safety of neuroimaging during pregnancy. Stress has been shown both to reduce
reward responsiveness and moderate effects of low reward responsiveness on depression, adding further
complexity to pathways to depression across time. Given the added stress and unique biological changes
associated with reward system adaptations, longitudinal work is needed to understand pathways through which
women develop perinatal depression. As part of a larger project, this research study will use safe and
temporally sensitive methods to measure neural reward responsiveness, stress, and depressive symptoms in
100 pregnant women at 20 weeks gestation, 34 weeks gestation, and 8 weeks postpartum. At each
assessment, participants will complete a monetary incentive delay task while electroencephalogram is
recorded in response to reward and loss feedback. Event-related potential (e.g., the reward positivity, a reliable
time-domain measure of initial reward responsiveness) and time-frequency data (i.e., delta and theta activity,
frequency-domain markers of sensitivity to rewards and negative outcomes, respectively) will be used to
measure neurophysiological response to reward. Participants will complete self-report and interview measures
of depressive symptoms and stress at each visit. Through the longitudinal collection of these data, the present
research will examine longitudinal associations between reduced reward responsiveness and depression using
an innovative bidirectional model to tease apart directionality of these associations across time (Specific Aim
1). This work will also test stress as a moderator of the associations between reward responsiveness and
depressive symptoms across the perinatal period (Specific Aim 2). This predoctoral fellowship award will bring
together a team of experts in their respective fields and allow for advanced training in life stress assessment,
perinatal depression and risk, EEG time-frequency analysis, and quantitative methods. Together, the research
project and training will provide the fellow the opportunity to develop necessary skills for a productive career as
a clinical scientist investigating alterations in emotional and social processing and how these processes
contribute to the development of mood disorders to inform intervention.

Public health relevance
PROJECT NARRATIVE Perinatal depression is a common and debilitating condition that is associated with significant negative outcomes for both mothers and their children, emphasizing the importance of identifying underlying processes that can be targeted in prevention efforts. As part of a larger longitudinal study, the current proposal will examine the associations between reward responsiveness, stress, and depressive symptoms across the perinatal period to understand perinatal depression risk and identify neurobiological targets for intervention. Results of this proposal will enhance our knowledge of pathways to depression during the perinatal period that can inform the development of targeted and personalized preventive interventions to reduce the burden and suffering associated with perinatal depression.